Early phase clinical trials of 211At-meta-astatobenzylguanidine for children with neuroblastoma and adults with advanced neuroendocrine cancers

PROJECT SUMMARY
An important hallmark of many neuroendocrine cancers, particularly neuroblastoma (NB) and
pheochromocytoma/paraganglioma (PPGL), is expression of the norepinephrine transporter (NET). NET
facilitates the uptake of catecholamines into vesicles. The guanethidine analog meta-iodobenzylguanidine
(MIBG) is a substrate for NET and, when synthesized with radioactive iodine (I) isotopes 123I and 131I, has been
approved by the FDA for imaging of NB and PPGL and, with 131I, for the therapy of PPGL. In relapsed/refractory
NB, 131I-MIBG has the highest reported single agent response rate.
While MIBG is safe and effective, toxicity is a limiting factor in adults. Additionally, complete remissions are
rare in adult patients with PPGL. NB is typically treated at much higher administered activity per patient mass
than adults can tolerate (the approved administered activity in adults is 296 MBq/kg whereas in children with
neuroblastoma the standard administered activity is 666 MBq/kg). Children often receive 131I-MIBG in
combination with other treatments and stem cell support. Complete remissions with combination therapy in NB
are common, but unfortunately relapsed disease is common. A putative mechanism for relapse is the presence
of micrometastatic disease, particularly in the marrow, that is very difficult to target with the b- particles emitted
by 131I-MIBG; b- travel up to millimeters in tissue and have low linear energy transfer. (LET) and so deposit very
little energy in microscopic sites of disease. The high mass amount of MIBG given in low specific activity
formulations of 131I-MIBG result in common infusion reactions in adults. Finally, the high abundance of high
energy g rays from 131I result in radiation safety and logistical challenges.
The a-particle-emitting halogen 211At can be used to synthesize 211At-MABG, which has biodistribution and
cancer uptake kinetics nearly identical to 131I-MIBG. Through extensive in vitro and in vivo pre-clinical studies,
we have shown that 211At-MABG is safe and effective. Only standard precautions are needed with 211At, and no
other significant radiation safety precautions. Additionally, the exceptionally high specific activity of 211At-MABG
will prevent pharmacologic effects with the potential for improved target to background ratio. Finally, the high
LET, relative biological effectiveness (RBE), and short path length of a-particles allows cytotoxicity to be
maintained down to microscopic disease.
Our overarching hypothesis is that 211At-MABG will improve upon 131I-MIBG in the treatment of
neuroendocrine cancers with less off-target toxicity and greater potential to eradicate microscopic sites of
disease. This should result in higher rates of durable disease control. Additionally, treatment will be more
readily given due to a much lower external radiation exposure. Finally, 211At can be cyclotron produced and is
therefore less subject to supply chain constraints facing nuclear reactor-produced isotopes like 131I. Building
upon our pre-clinical experience we propose to test 211At-MABG in pediatric and adult patients.

Public health relevance
PROJECT NARRATIVE Neuroblastoma in children and pheochromocytoma/paraganglioma in adults are devastating neuroendocrine cancers and the majority of patients with advanced disease are not cured with current treatments. Radiopharmaceutical therapies have shown efficacy in these diseases but are limited by toxicity and radiation safety concerns. We propose to test 211Astatine-meta-astatobenzylguanidine in two parallel Phase I trials and children and adults, respectively, to determine the recommended Phase II dose as well as to assess early signals of efficacy.